Leadership Administrative Core-LAC

SUMMARY- LEADARSHIP
ADMINISTRATIVE CORE
The purpose of LAC is to provide administrative support for all program-related activities, mentoring for the PI
of the Early Stage Investigator lead projects, interface with the National Institutes of Health, the University of
Mississippi Medical Center (UMMC) administration, the UMMC Grants and Contracts office, all departments
represented in the SCORE and the investigators of the SCORE. The Program Director is responsible for the
scientific and financial management of the program and will be assisted by the Associate Director. The
administrative staff of this core is responsible for all purchasing and fiscal management, personnel, program-
related travel by all of the investigators and visits by invited ESI mentoring committee and external speakers,
and reports to the National Institutes of Health. The LAC will disseminates important information to the
SCORE investigators, organize scientific meetings and seminars related to the program, and coordinate
assessment of research progress by the Internal and External Advisory Committees.

Public health relevance
Leadership Administrative Core - Narrative The main purpose of Leadership Administrative Core (LAC) is to provide administrative support for all program-related activities, mentoring for the ESI lead project, and to interface with the National Institutes of Health, the University of Mississippi Medical Center (UMMC) administration, the UMMC Grants and Contracts office, all departments and the investigators of the SCORE. The Program Director is responsible for the scientific and financial management of the program and will be assisted by the Co-Director. The administrative staff of this core is responsible for all purchasing and fiscal management, preparation of manuscripts and posters for national meetings, personnel, program-related travel by the investigators and visits by invited consultants and speakers, and reports to the National Institutes of Health.